MASS: Muscle and disease in postmenopausal women

ABSTRACT
Sarcopenia (low muscle mass) and diabetes are two highly prevalent and disabling chronic health conditions
affecting older women. There is emerging evidence that diabetes and impaired insulin-glucose homeostasis
may accelerate age-related loss of muscle mass. It is critically important to examine modifiable risk factors
(e.g., muscle mass, dysglycemia) that contribute to risk of functional impairment, falls and fractures (the 3Fs) in
older adults. Our study will address a key knowledge gap: the extent to which insulin-glucose homeostasis is
associated with loss of muscle mass over time in aging women and whether this varies by race/ethnicity.
Moreover, this study will examine the feedback loop between impaired insulin-glucose homeostasis and loss of
skeletal muscle mass. Until recently, the ability to fully characterize change in muscle mass in large studies of
community dwelling older adults has been limited by challenges associated with obtaining measures of muscle
mass. This is a critical barrier to progress. This project will use a novel at-home remote sample collection
protocol (D3Cr method) and finger-prick blood collection kit to examine longitudinal change in muscle mass
and insulin-glucose homeostasis in 3177 postmenopausal women from the Women’s Health Initiative (WHI).
The WHI is a large, ongoing prospective cohort study of postmenopausal women with 30 years of follow-up.
Study participants will be drawn from a WHI sub-cohort, the Long Life Study 2 (LLS2), a diverse cohort of older
women (56% from racial/ethnic minority groups; mean age 85 years). The study aims are to: 1) provide insight
into longitudinal patterns of change in D3Cr-muscle mass in postmenopausal women as they age, and their
risk for functional decline increases, by race/ethnicity, diabetes status, and according to level of glycemic
control, 2) examine the cyclical relationship between impaired insulin-glucose homeostasis and change in
D3Cr-muscle mass using advanced statistical approaches, and 3) use machine learning methods to develop
multivariate risk stratification algorithms, including D3Cr-muscle mass, indices of impaired insulin-glucose
homeostasis, and objective measures of functional capacity (grip strength, gait speed), to identify
postmenopausal women at highest risk of the 3 Fs. This project addresses an urgent need identified by the
NIA for research on geroscience, including research that determines the rate of aging processes and
mechanisms underlying age-related change. In the future, these results will be used to develop interventions
designed to mitigate harmful effects of sarcopenia and diabetes and promote healthy aging in postmenopausal
women, including women from racial/ethnic minority groups that are typically underrepresented in health
research.

Public health relevance
PROJECT NARRATIVE This study is focused on longitudinal change in muscle mass and how it relates to impaired insulin-glucose homeostasis, diabetes, and adverse health outcomes (functional limitation, falls, and fractures) in a diverse cohort of older women (56% from racial/ethnic minority groups). The results will provide insight into mechanisms underlying sarcopenia and diabetes/pre-diabetes that will enhance our ability to develop geroprotective or gerotherapeutic interventions in the future. The novel remote measurement approach for assessment of muscle mass via the D3-creatine (D3Cr) dilution method has potential to revolutionize screening for sarcopenia in clinical settings and public health research.